Proof-of-Concept and Mechanistic Studies to Repurpose Erectile Dysfunction Drugs for Elderly Females

PROJECT SUMMARY
Alzheimer’s disease (AD) is a public health crisis with no effective treatment1. Preclinical studies using a
group of drugs—commonly termed "PDE5A inhibitors”, which include tadalafil, vardenafil and sildenafil—have
shown that the suppression of the enzyme phosphodiesterase 5A (PDE5A) can improve memory in mice prone
to AD. This begs the question whether these drugs, currently in clinical use for erectile dysfunction and
pulmonary artery hypertension, can be repurposed for AD patients. Such an approach would merit a thorough
investigation into the mechanism of action of PDE5A inhibitors on brain function. Complexities however arise
from the fact that the structurally–related enzyme PDE11A is also expressed abundantly in various AD–
vulnerable brain regions, such as the cortex and hippocampus, and that tadalafil potently inhibits PDE11A,
albeit with a 7–fold higher IC50 compared with PDE5A. It is therefore imperative that we (a) tease apart the
relative effects of inhibiting PDE5A and PDE11A on cognitive loss, and (b) determine whether PDE11A is itself
an actionable target. Towards these goals, we will first map the expression of Pde5a and Pde11a transcripts
using qPCR, RNAscope and immunohistochemistry in various brain regions and sub–regions of aged mice
and 3xTg mice (Specific Aim 1). We will then inject CRISPR constructs for Pde5a and Pde11a stereotactically
into the hippocampus of 3xTg mice to determine whether PDE5A and/or PDE11A inhibition prevent cognitive
decline, measured by the Novel Object Recognition and Morris Water Maze tests, and amyloidogenic protein
accumulation (Specific Aim 2). Consistent with the goals of the Administrative Supplement under PA–20–272,
NOT–AG–22–025, this 1–year project will yield preliminary data towards a new R01 application to fully study a
role for PDE5A and PDE11A in brain function.

Public health relevance
PROJECT NARRATIVE Our parent NIH grant R01 AG071870 seeks to study whether we can repurpose drugs currently used for erectile dysfunction—PDE5A inhibitors, such as Viagra and Cialis—for post–menopausal osteoporosis. Interestingly, the targets on which these drugs act—phosphodiesterase 5A (PDE5A), together with its counterpart PDE11A—are also present in brain regions that are vulnerable to Alzheimer’s disease (AD), In this 1–year proposal, we will use old mice and AD mice to tease out the relative effects of turning off PDE5A vs. PDE11A in reversing AD in men and women.